Enhancing Primary Care Capacity for Cancer Survivorship Care Delivery in Community Health Clinics

PROJECT SUMMARY
The US has over 18 million cancer survivors (persons diagnosed with cancer no matter where they are in the
course of their disease), estimated to increase to 22 million by 2030. The majority of formalized cancer
survivorship care is organized and delivered by oncology, often through academic and private cancer centers.
Because 70% of cancer survivors also have other chronic conditions and receive care from multiple clinical
teams, suboptimal coordination of that care poses a significant barrier to optimal health outcomes. The growing
number of survivors and anticipated shortage of oncology subspecialists pose significant additional challenges
to delivering high quality survivorship care.
Primary care is uniquely suited to deliver whole person and coordinated care for cancer survivors because, at
its core, it prioritizes, personalizes, and integrates health care for all conditions. This view is endorsed by the
National Academy of Medicine and National Comprehensive Cancer Network (NCCN) guidelines recommend
that cancer survivors stay connected with their primary care clinicians (PCCs). Despite this growing recognition
of the importance of primary care, primary care teams experience key challenges in delivering high-quality
survivorship care especially for under- and uninsured cancer survivors who experience disproportionately
worse health outcomes and rely on community health centers (CHCs) for consistent health care.
Leveraging our team has a 10-year program of research in Texas CHCs, we propose a pragmatic trial testing
implementation and effectiveness of a primary care-based survivorship care delivery intervention among eight
Texas CHC sites. Specifically, we propose to:
(1) Implement a system-level cancer survivorship care delivery intervention in partnership with CHC clinicians,
patients, and community representatives.
(2) Test effectiveness of the intervention to improve patient and clinician outcomes using a stepped-wedge
cluster-randomized trial design.
(3) Evaluate implementation of the intervention using an iterative, concurrent mixed-methods approach guided
by the Practice Change Model.
Our overall study is guided by the Practical, Robust, Implementation, & Sustainability Model (PRISM) to
maximize implementation and sustainment within each CHC’s local context. Our study recognizes the reality
that care of underserved cancer survivors is increasingly occurring in primary care CHCs. Together with our
CHC partners, we will generate the evidence-base needed for a generalist primary care-based care delivery
model with the goal of disseminating and scaling to optimize cancer survivorship care equitably.

Public health relevance
PROJECT NARRATIVE Primary care clinicians are rarely part of the multi-disciplinary survivorship care delivered by oncology teams, despite National Comprehensive Cancer Network guidelines and National Academy of Medicine reports recommending that cancer survivors stay connected with their primary care clinicians. Leveraging our team’s program of research in primary care and cancer survivorship care delivery, we will conduct a pragmatic trial testing implementation and effectiveness of a survivorship care delivery intervention among eight Community Health Center sites across Texas. Guided by theory-based conceptual models to maximize the likelihood of successful implementation and sustainment within each local context, our evaluation will generate rich and actionable lessons to scale this generalist primary care-based care delivery model to improve cancer survivorship care equitably.